Developing photoreceptor repair for macular degeneration therapy.

There is no available treatment for vision loss in dry age-related macular degeneration, a leading
cause of blindness in adults over 55 years of age. Vision loss occurs when retinal pigment
epithelium (RPE) and cone photoreceptors degenerate, so transplanting them is a potential
treatment to restore vision. Using a novel mouse cone and RPE transplantation model system to
study cone-RPE interactions in a regenerative paradigm, we will characterize donor cone
maturation over the long term, reveal age-related impact on regeneration efficacy, and identify
cues in specific recipient cell types that promote functional vision repair.

Public health relevance
Project Narrative There is no available treatment for vision loss in dry age-related macular degeneration, a leading cause of blindness in adults over 55 years of age. Vision loss occurs when retinal pigment epithelium (RPE) and cone photoreceptors degenerate, so transplanting them is a potential treatment to restore vision. Using a novel mouse cone and RPE transplantation model system to study cone–RPE interactions in a regenerative paradigm, we will characterize donor cone maturation over the long term, reveal age-related impact on regeneration efficacy, and identify cues in specific recipient cell types that promote functional vision repair.